Clinical Research Support for the CCR

The Clinical Support Laboratory offers processing, tracking, and testing of a broad range of clinical samples. Support can begin at the early stages of clinical trial development to aid in developing a comprehensive strategy for sample collection, processing, and testing with a special emphasis on immunologic testing. The lab collaborates with partners to develop customized assays or transfer existing assay technology with assay validation, data analysis and interpretation of results. Processing specializes in PBMC isolation and controlled rate freezing, ELISA based biomarker testing, and multiplex biomarker analysis using the Meso Scale Discovery (MSD), Olink, and Luminex platforms, and a broad spectrum of bioassays to assess cellular responses to antigens and mitogens including ELISPOT, cytotoxicity assays (e.g., ADCC), and proliferation assays.